METABOLIC END PRODUCTS OF LINOLEIC ACID METABOLISM

This investigation proposes to determine the utility of measuring metabolic end products of linoleic acid to assess total dietary fat consumed, plasma phospholipid fatty acids, and specific urinary eicosanoids: 13, 14-dihydro-15-keto PGE2, 2, 3-dinor TXB2, and a lipid peroxidation compound, 8-iso-PGF2a.